Examining Early Life Risk Factors and Patterns of Screening for Early-Onset Colorectal Cancer

PROJECT SUMMARY/ABSTRACT
In the United States (US), the incidence of early-onset colorectal cancer (EOCRC), defined as colorectal
cancer (CRC) diagnosed among individuals <50 years of age, has been increasing rapidly. Compared to late-
onset CRC (i.e., CRC diagnosed among individuals ≥50 years of age), EOCRC is characterized by more
aggressive pathology and distinct genetic profiles, indicating that the etiology of EOCRC may be distinct. There
have been a limited number of studies examining the risk factors of EOCRC, and none have focused on early
life risk factors, which could be particularly relevant to early-onset diseases. Over the past few years, the
American Cancer Society and the US Preventative Services Task Force reduced the recommended age of CRC
screening from 50 years to 45 years, and the COVID-19 pandemic influenced the provision of preventative
services across the country. These events could impact the temporal and geographic patterns of screening for
EOCRC, but no study has systematically assessed such impacts in a large sample of the US population. The
proposed study aims to 1) identify early-life risk factors of EOCRC and 2) evaluate spatiotemporal patterns of
EOCRC screening in the US. For the first aim, we will conduct a nested case-control study within the California
birth cohort and compare the birth characteristics between 1200 EOCRC cases and 60,000 control subjects
matched on year of birth. In addition, we will obtain birth address matched social, behavioral, lifestyle, and
environmental factors from the Centers for Disease Control and Prevention and the Environmental Protection
Agency and compare these neighborhood-level factors between the 1,200 cases and 60,000 controls. Two key
methodological challenges will be addressed: a) spatial autocorrelation, the tendency of adjacent geographic
units to share similar attributes; b) the modifiable areal unit problem, a biasing effect that occurs when observed
associations between exposures and outcomes vary based on the scale of the chosen geographic unit. For the
second aim, we will assess temporal patterns in EOCRC screening and identify factors associated with potential
regional variation in screening by leveraging unique claims data from Blue Cross Blue Shield (BCBS), the largest
insurance provider in the US that covers one-third of all Americans. Approximately 4 million beneficiaries aged
45-49 years are enrolled in BCBS each year, allowing us a great opportunity to assess both stool-based and
structural CRC screening tests. With a rigorous design and unparalleled sample sizes, the proposed study
addresses research questions with clear public health significance, is very innovative, and will probably yield a
high impact on our knowledge about the etiology and screening of EOCRC – a critically understudied field
according to the National Cancer Institute. In addition, by bringing together a multidisciplinary team of experts in
cancer epidemiology, health services research, spatial statistics, gastrointestinal oncology, and geographic
information systems science, this study will contribute to the training of a promising minority predoctoral fellow
with aspirations to pursue a career in cancer epidemiology research and improve the health status for all.

Public health relevance
PROJECT NARRATIVE Very little is known regarding the underlying reasons why the rate of colorectal cancer has been increasing among those <50 years of age and how the patterns of screening might have changed over time in this age group. This study aims to understand the risk factors associated with early-onset colorectal cancer and factors that may explain differences in screening patterns across various geographic regions. Results from this study may be utilized to help identify individuals who are at a higher risk for early-onset colorectal cancer or regions that have low levels of screening, so interventions could be designed and implemented to reduce disease risk and improve screening.